EFFECTS OF OBESITY, BODY FAT DISTRIBUTION AND ESTROGEN

The study will evaluate the effects of aging, body fat composition, body fat distribution, and both endogenous and exogenous sex steroids on growth hormone and Insulin-like Growth Factor I secretion in postmenopausal women.